Improving Weight Loss in Early Non-responders to Behavioral Treatment

PROJECT SUMMARY/ABSTRACT
My long-term career goal is to be an independent investigator who develops effective obesity treatments and
matches these treatments to patients' characteristics. Through my training in clinical psychology, I gained skills in
the development and delivery of behavioral treatments (BTs) for obesity and in conducting randomized controlled
trials (RCTs) to test their efficacy. As a postdoctoral fellow, I was then introduced to obesity pharmacotherapy, but
still have limited experience in this area. In order to successfully develop a career in precision medicine for obesity, I
will need additional training in behavioral, biological, and pharmacological influences on body weight. The
proposed K23 award will allow me to devote 95% effort to filling critical gaps in my training and to conducting
research that will prepare me to be an independent investigator in obesity treatment.
My training plan will prepare me for an independent research career by increasing my knowledge in three key areas:
1) behavioral phenotypes associated with obesity and methods for their objective measurement; 2) neuroendocrine
mechanisms of energy balance regulation that may impact weight loss; and 3) the use of pharmacologic agents to
improve weight loss. I will accomplish these objectives by receiving guidance from mentors, engaging in hands-on
research training, and completing relevant coursework and seminars.
My research project will complement these training goals by examining behavioral phenotypes and neuroendocrine
biomarkers as predictors of early weight loss and by testing whether medication enhances weight loss in patients
with a suboptimal early response to BT alone. Participants will complete an initial assessment of behavioral and
biological characteristics, followed by 4 weeks of BT. Those who lose < 2.0% of initial weight during the run-in will
then be randomly assigned to an additional 24 weeks of: 1) BT plus placebo; or 2) BT plus medication (liraglutide
3.0 mg). I believe that low satiety will predict poor early weight loss with BT and that pharmacotherapy will enhance
24-week weight loss for patients with suboptimal response to BT. This project could shape best practice
recommendations for obesity treatment and ultimately result in algorithms for matching treatments to patient
characteristics.
The environment at the Center for Weight and Eating Disorders at the University of Pennsylvania is well-equipped
with staff, resources, and infrastructure to support the proposed project. I will also access state-of-the-art facilities,
coursework, and seminars at Penn to complete my research and training goals. My mentorship team will be led by
Dr. Thomas Wadden (Professor of Psychology) and includes training from Dr. Tanja Kral (Associate Professor of
Nursing) in behavioral phenotypes of obesity and Dr. Matthew Hayes (Associate Professor of Nutritional
Neuroscience) in mechanisms of energy balance. This comprehensive, interdisciplinary mentored approach will
allow me to acquire knowledge in areas essential to my career goals, implement the proposed research plan, and
develop a successful R01 application prior to the end of the K23 award.

Public health relevance
PROJECT NARRATIVE A substantial minority of patients treated with behavioral therapy (BT) for obesity fail to achieve clinically meaningful losses of ≥ 5% of initial weight. Medications approved by the Food and Drug Administration (FDA) for weight management enhance average weight losses when combined with BT; however, their use among patients with suboptimal response to BT has never been tested in a randomized controlled trial. The proposed study seeks to identify behavioral and biological phenotypes predictive of poor response to BT and test whether providing pharmacotherapy improves the induction of weight loss for participants who lose minimal weight with 4 weeks of BT alone (a strong predictor of later failure to lose ≥ 5% of initial weight with that treatment).